Outreach and Dissemination

The scientific and educational concepts stemming from the research conducted in the Center will not be conventional in physics or in cancer biology. Therefore, we will adopt a proactive, multifaceted approach for outreach activities and results dissemination. The overall mission of the Outreach and Dissemination Unit is to disseminate research results, as well educational concepts resulting from the Center's activities and outreach to various academic, industrial, and government communities. The outreach efforts of the Center for Cancer Physics will include the following components: (1) the Seminar Series on the Physics of Cancer (2) the Annual Two-Day Symposium/Workshop, (3) Web-Based Modules, (4) the Center Website, (5) the Center Newsletter (6) Video-Based Research and Educational Modules, (7) Outreach through Pilot Projects, (8) the Center Tool Repository, (9) Industrial and National Labs Outreach, (10) the Database of Students in the Center, and (11) the Physics of Cancer Roadshow, described below: